Malaria and Mosquito/Tick-borne Diseases

Project Summary
The training program in Malaria and Mosquito/Tick-borne Diseases research requests support for three
predoctoral students selected from a large pool of highly qualified applicants and two postdoctoral positions
both for a two-year fellowship. The training program is situated within the Molecular Microbiology and
Immunology and Epidemiology departments of the Johns Hopkins Bloomberg School of Public Health as well
as Pharmacology in the School of Medicine. The 25 training faculty, across three departments, have a wide
range of collaborative experience and expertise in cellular and molecular biology, immunology, epidemiology
genomics, and therapeutic interventions of malaria as well as with the mosquito and tick vectors associated
with malaria, bacteria and viral transmission. The state-of-the-art insectary is a training facility which generates
mosquitoes weekly as the foundational nexus for novel multi-disciplinary, collaborative cutting-edge research.
A separate tickery will be built. The goal of the training program is to provide trainees with both a firm
foundation in the basic disciplines (microbiology, vector biology and immunology) necessary for the study of
mosquito/tick-borne diseases as well as a critical perspective that will enable them to apply their knowledge
creatively to public health problems or outbreaks at a national or global scale. Each predoctoral student will
have already completed a series of required courses in the basic disciplines of cell and molecular biology,
biochemistry, epidemiology, bacteriology, parasitology, virology, vector biology and immunology, as well as
courses in research ethics and public health perspectives. Students who have finished required courses, three
10-week laboratory rotations and have selected a thesis advisor in a mosquito/tick-borne diseases laboratory
will be candidates for this doctoral training program. Based on a competitive assessment of academic
excellence and a demonstrated commitment to work in a mosquito/tick-borne diseases laboratory predoctoral
students will be selected by the training faculty committee in the spring of the second year, and postdoctoral
fellows are eligible at any time in their training. Mentoring training is also required for PhD training faculty. A
major innovation developed during the current funding cycle is a new certificate-granting program named
Rigor, Reproducibility and Responsibility (R3). Both predoctoral and postdoctoral appointed trainees will be
required to take a single R3 courses each year of appointment. The R3 curriculum is vigorous, definitive, school
and departmental response to responsible conduct of research issues. Predoctoral student academic and
research progress will be monitored by the departmental Graduate Program Committee and by the Thesis
Advisory Committee, with special attention to student’s Individual Development Plan. Postdoctoral fellows will
also have a Fellowship Advisory Committee and Individual Development Plan.

Public health relevance
Narrative This Malaria and Mosquito/Tick-borne Diseases training program for 3 doctoral students and 2 postdoctoral fellows is highly relevant to national interests in vector-borne infectious diseases. The program will train students broadly in the molecular aspects of malaria and mosquito arboviral biology and pathogenesis, as well as in the ecology and epidemiology of mosquito/tick-borne pathogens and the role of mosquito vectors in transmission. The public health relevance derives from not only the mosquito disease specific knowledge (Dengue and Zika as well as malaria), but also general scientific concepts in critical thinking focused on Rigor, Reproducibility and Responsibility (R3).